TEST TO DETECT RESIDUAL SPONGIFORM ENCEPHALOPATHY ON ENVIRONMENTAL SURFACES

This new project was only approved in the last month of FY96. Progress will depend on availability of space to house rodents.